Development of an accessible Cognitive Behavioral Therapy digital therapeutic for individuals with Long COVID

PROJECT SUMMARY
The over 100 million cases of COVID-19 that have occurred in the US since 2019 have spurred a ‘pandemic
within a pandemic’ as up to 70% of COVID survivors experience long-term medical conditions and 10-20%
develop post-acute sequelae of SARS-CoV-2 infection (PASC) or ‘Long COVID’. Strikingly, 6 weeks after
diagnosis, 30% of Long COVID patients require assistance for daily activities and over 75% report impaired
ability to work. Symptoms of Long COVID include both physical and psychological impairments. 30% of COVID
patients develop vision issues that can persist into Long COVID, and over two-thirds of Long COVID patients
present with serious mental health symptoms. Thus, there is a critical need for accessible digital mental
health interventions to serve the growing population of Long COVID patients. Cognitive behavioral therapies
(CBTs) are a known effective treatment for depression, anxiety and other mental health disorders, and the rise
of digital health offers a new opportunity to provide large-scale, cost-effective, accessible CBT services to
patients in populations where access to mental health care is difficult to obtain. In the case of Long COVID,
access to effective mental health care is complicated by the heterogenous nature of the population and a current
lack of consensus guidelines for management of Long COVID and related mental health impacts. Despite the
enormous negative impact of Long COVID on mental health, patients describe gaining access to appropriately
personalized treatment as ‘complex, difficult, and exhausting’. A readily accessible, highly personalized, and
cost-effective means of CBT digital health services would be ideally positioned to meet the critical and rapidly
growing mental health needs of Long COVID patients. At Toivoa, Inc., we are closing this treatment gap with
the first FDA-authorized, accessible, highly personalized digital mental health therapeutic – Rauha –
which integrates the digital delivery of expert CBT from licensed clinical psychologists with personalized support
and guidance mediated via National Health and Wellness Board Certified (NHWBC) certified mental health
coaches. Our Rauha platform is currently designed for adults with hearing loss and mobility disabilities, and this
project will seek to optimize Rauha to meet the unique accessibility needs of Long COVID patients. The
overarching goals of this Phase I SBIR project are to gather peer-review on Rauha from a panel of clinical experts
and advisory boards of patients, caregivers, and mental health coaches to reach a consensus opinion on digital
therapeutic content for Long COVID patients addressing their mental health needs (Aim 1), customize Rauha to
best serve Long COVID patients and their caregivers (Aim 2), and conduct a human factors study with Long
COVID patients to evaluate the usability and acceptability of Rauha’s personalized CBT digital therapeutic
content with an integrated mental health coach with shared life experiences for addressing their mental health
needs (Aim 3). Successful completion of Phase I will position Toivoa for a Phase II program to conduct a powered
randomized control clinical trial to evaluate the efficacy of Rauha among Long COVID patients.

Public health relevance
PROJECT NARRATIVE ‘Long COVID’ develops in 10-20% of COVID-19 patients, leading to symptoms such as fatigue and brain fog, in addition to new mental health conditions or exacerbation of pre-existing mental health conditions. At Toivoa Inc., we are building Rauha, the first FDA-authorized digital platform that provides a comprehensive, highly personalized, and accessible cognitive behavioral therapy (CBT) intervention for Long COVID patients. By developing Rauha to meet the needs of the growing Long COVID patient population, Toivoa aims to provide desperately needed personalized mental health support that is designed to be accessible to people with disabilities, including those associated with and exacerbated by Long COVID.